Evolution of new protein function in the multi-protein, multi-functional Toll-like receptor 4 complex

SUMMARY
Understanding the evolution of protein function is a central goal in evolutionary biochemistry. Most mechanistic
work on this problem has focused on single proteins with single functions; however, proteins often work as
members of multi-functional, multi-protein complexes. How can evolution optimize one protein function
without breaking another? How are new proteins integrated into multi-protein complexes? Answering these and
other questions requires mechanistic studies of the natural evolution of multi-functional, multi-protein
complexes.
To answer these questions, we propose studying the evolution of Toll-like receptor 4 (TLR4)—a multi-protein,
multi-functional protein complex found in vertebrate animals. This complex is central to how animals respond
to both infection and tissue damage. It is the subject of intense interest, both from the perspective a basic biology
and as a drug target for inflammatory disorders. The complex evolved in serial over hundreds of millions of years.
In this work, we will pose—and answer—three questions: 1) How did the ability of the complex to recognize pro-
inflammatory signals change over the last 300 million years? 2) What were the evolutionary forces and processes
that led to these functional changes? 3) How did a completely new protein evolve in the ancestor of land animals
and become integrated into the complex? To answer these questions, we will employ a combination of
phylogenetic analysis, ancestral sequence reconstruction, high-throughput protein characterization,
biochemical/biophysical studies, careful functional characterization, and in vivo experiments in zebrafish.
This work will provide unprecedented understanding of the mechanisms—both biochemical and evolutionary—
that lead to new function in multi-functional protein complexes. By specifically studying the evolutionary
process that led to the human TLR4 complex, this work will also provide a lens through which we can interpret
animal model studies of innate immunity and apply their findings to human biology. And, finally, an
evolutionary approach is a powerful means to dissect how proteins work. Our results will provide deep insight
into how this important protein complex functions and can be manipulated to achieve better human health
outcomes.

Public health relevance
Project Narrative We propose studying the evolution of innate immune proteins that are key players in healthy and harmful inflammation. Understanding how these proteins evolved will provide insight into how the proteins function, and thus help us better target these proteins for treatment. The proposed work will also provide important insight into how natural proteins evolve new functions.